Gulf South Minority/Underserved Clinical Trials Network (Gulf South M/U CTN)

Virtual Research Nurse Program (VRN) Addressing Clinical Trials Research Personnel Shortage
Most adult cancer patients in the US are diagnosed and treated in community oncology practices. However <5%
of patients participate in clinical trials, thus limiting the testing and implementation of scientific advances in “real
world” settings. In addition to the well described patient and physician related barriers to clinical trials, the recent
changes to the workforce brought about by the COVID-19, including “work from home” initiatives have greatly
decreased the number of trained clinical trials personnel. These changes more severely affect community
oncology practices in both urban and rural locations where research infrastructure is limited and the ability to
adapt to these changes is difficult. The Gulf South NCORP community sites have experienced a severe
reduction in accruals due primarily to research personnel shortage. We established a “Virtual Research
Nurse” program to provide research infrastructure (regulatory, data management and research nurse) to
community sites through virtual means. Using a HIPAA-compliant communication platform we have helped
urban and a rural oncology practices select and open clinical trials of interest, screen and identify candidate
patients and facilitate their enrollment and follow-up. This approach is distinct from traditional telemedicine, in
that telemedicine primarily provides physician services to a distant clinical location, while the VRN program
provides the research infrastructure and functions to community oncologists seeking to enroll patients in clinical
trials. Our preliminary data shows that a centrally located VRN efficiently screens the community clinics,
identifies potential candidates for clinical trials and with the community oncologist enrolls patients on clinical
trials. The VRN also provides long-term management of the patient. Furthermore, in collaboration with
Medidata Solutions we will further streamline the implementation of VRN by ensuring that data collected is
seamlessly transferred to the RAVE system, thus minimizing the error-prone process transcribing data by hand.
We believe that the VRN will significantly facilitate the participation of community oncology practices and
patients in clinical trials and help address the severe shortage of trained clinical trials personnel and research
infrastructure. We propose to: Specific Aim 1a. Complete the development of the VRN prototype in collaboration
with Medidata Solutions to have a fully functional platform that can be used in NCORP sites. This will be a Proof
Of Concept (POC) program designed to demonstrate the use of technology, training, and clinical trial expertise
to support these clinics and patients. 1b. Expand the number of sites to test the integrated VRN program to 4
sites (2 urban and 2 rural) to determine and compare the effect of implementing a VRN program at community
oncology practices in urban and rural locations. Aim 2: Develop standard operating procedures (SOPs) for the
implementation of the VRN program at other clinical centers.

Public health relevance
Virtual Research Nurse Program (VRN) Addressing Clinical Trials Research Personnel Shortage Project Narrative Cancer patients in clinical trials have improved outcomes in great part because they are closely followed by a team of highly experienced health care providers. However less than 10% of adult cancer patients participate in clinical trials. This problem has been further aggravated by the COVID-19 pandemic that precipitated the departure of research personnel from academic and community practices to private clinical research organizations that offer “work from home” opportunities. Low participation is even more pronounced for minority patients and those in rural and underserved areas. Consequently the National Cancer Institute (NCI) and Cancer Moonshot Initiative have emphasized the need for novel approaches to increase study participation and compliance of patients in rural/underserved areas. At the Gulf South NCI Community Oncology Program (NCORP) in Louisiana we have explored novel uses of existing telehealth communications and patient engagement technologies to support the enrollment of patients in academic and community oncology practices in urban and rural locations. The complexity of trial documentation and patient selection requires highly-trained personnel that are coveted by private CRO’s and are unlikely to remain in smaller academic or private practices. Using existing telecommunication platforms, our experienced centrally-located research nurses can effectively screen the roster of patients at a distant clinic prior to the patient’s visit, identify candidates for clinical studies and work with the local physician to facilitate the enrollment of patients into clinical trials and manage their follow-up plans. Distinct from traditional telemedicine approaches that “bring the physicians to the patient”, the VRN program “brings the research support” to the distant oncology practices. Our working hypothesis is that ongoing access to trained clinical support in the form of a VRN, will increase participation of patients in clinical trials at academic and community practices. It will also increase compliance, study retention, and overall satisfaction amongst trial participants. We propose to complete the development of the Virtual Research Nurse program by working in collaboration with the Product team at Medidata Solutions. Medidata’s active support of NCI trials through Medidata Rave, coupled with the innovative use of the myMedidata patient portal will streamline the process, integrate the existing clinical trial databases, establish novel video link communications and ensure the timely and safe transfer of clinical trial data to the NCI’s RAVE program. To achieve this we plan to use the following Specific Aims: Aim 1: Test a fully integrated VRN program using the Gulf South NCORP experience and Medidata Solutions technology. This will be a Proof Of Concept (POC) program designed to demonstrate the use of technology, training, and clinical trial expertise to support these clinics and patients. 1a. Integrate the VRN workflow developed by Gulf South NCORP with Medidata Solutions clinical trial data bases and telecommunications technologies. This will include Rave (already in use on NCI studies), myMedidata eConsent, eCOA, and LIVE video visits. . 2a. Expand the number of sites to test the integrated VRN program to 4 sites (2 urban and 2 rural) with different clinical practice characteristics and levels of experience. Milestone: Enrollment of eighty new patients using the VRN. We will document the process and determine potential barriers and develop strategies to overcome them. Aim 2: Develop standard operating procedures (SOPs) for the implementation of the VRN program at other clinical centers. By documenting the implementation strategies and developing a configuration profile for other clinical centers, NCI will be able to enable a “best-practices” guideline to support the entire study, or a portfolio of studies.